GROWTH HORMONE PLUS PULMONARY REHABILITATION FOR COPD

This study tests the hypothesis that the treatment of chronic obstructive pulmonary disease (COPD) with recombinant human growth hormone (hGH) plus pulmonary rehabilitation is significantly superior to treat of pulmonary rehabilitation alone in a double-blind, placebo-controlled trial.